REPOSITORY FOR STORAGE &DISTRIBUTION OF BIOLOGICALS

The Biological Carcinogenesis Branch is responsible for maintaining a coordinating program of research resources support to meet the needs of both intramural and extramural cancer research investigators. The objectives of this project include the maintenance and operation of facilities for the storage of biologic reagents at specified temperatures ranging from minus lOO degrees celsius to four degrees celsius. This is done in accordance with procedures which maintain the integrity of the materials and the safety of employees. The objectives of this project also include the replenishment of reagents; the receipt and storage of reagents; the retrieval from storage, packaging and shipment of materials as directed; the collections of charges for materials shipped; the maintenance of an accurate inventory of materials and to account and disperse monies as specified.